The role of acetogenic, methanogenic, and sulfate-reducing bacteria in oxalate metabolism and hyperoxaluria

PROJECT SUMMARY/ABSTRACT
In the United States, the incidence of urinary stone disease (USD) is rapidly increasing, affecting 8.8% of the
population in 2010, up from 2.6% in 1968, with half of patients exhibiting recurrent episodes. Calcium oxalate
stones comprise approximately 80% of USD cases and oxalate metabolism is provided exclusively by gut
bacteria. The canonical hypothesis for the increase in USD incidence is that a single oxalate-degrading species,
Oxalobacter formigenes, is sufficient to reduce urinary oxalate excretion enough to prevent calcium oxalate
stone formation and is lost due to oral antibiotic use. However, in a paradigm-shifting series of studies, we have
found that 1) O. formigenes is neither necessary nor sufficient to reduce urinary oxalate excretion or prevent
USD; 2) Oral antibiotics increase the risk of USD regardless of their effect on O. formigenes; 3) A functionally
diverse oxalate-degrading microbial network (ODMN) is responsible for oxalate metabolism rather than a single
species; 4) The ODMN prevents the toxic effects of exogenous oxalate on the host and the microbiome; and 5)
The ODMN is negatively associated with oral antibiotics in both animal models and in a clinical cohort of USD
patients. Given these new data, it is critical to further understand how the ODMN maintains a homeostatic
environment relative to oxalate and contributes to the prevention of USD. The objective of the current proposal
is to establish the host-microbe mechanisms through which the ODMN facilitates persistent oxalate metabolism
in vivo to prevent enteric hyperoxaluria. Oxalate can either stimulate or inhibit gut microbial diversity depending
on the baseline composition. Our preliminary work shows that when laboratory rodents with a reduced ODMN
are exposed to exogenous oxalate, urinary oxalate excretion gradually increases over time, there is a loss of
microbial diversity, and signs increased gut permeability are apparent. These effects are reversed in animals
with a robust ODMN. The by-products of oxalate metabolism are formate and CO2. Formate has known toxic
effects for both humans and bacteria. However, acetogenic, methanogenic, and sulfate-reducing bacteria
(AMS), which can use formate and CO2 as carbon and energy sources, are consistently present in the ODMN.
Thus, we propose oxalate-degrading and AMS bacteria exhibit metabolic interactions that synergistically
promote persistent colonization and reduce inflammation of host intestinal epithelium, thereby reducing oxalate
absorption. To test this hypothesis, we will Investigate the mechanistic microbe-microbe and host-microbe
interactions that modulate enteric hyperoxaluria, determine the role of AMS bacteria in preventing hyperoxaluria,
and investigate the mechanisms that drive the loss of ODMN function in a clinical cohort of patients.

Public health relevance
PROJECT NARRATIVE The proposed study aims to comprehensively delineate the host-microbe mechanisms that modulate enteric hyperoxaluria within a complex host-microbe environment and determine the effect of oral antibiotics on that environment in humanized mice. Understanding oxalate metabolism at a systems level will provide novel opportunities for the development of bacteriotherapies to alleviate recurrent urinary stone disease (USD) that are tailored to individual patients. Considering the depth of interactions between oxalate and the gut microbiota as a whole, understanding how the microbiota regulates oxalate is highly significant and critical for the development of effective and persistent bacteriotherapies for recurrent USD.